Controlling the upstream migration of neutrophils by manipulating the function of Mac-1 and LFA-1

Summary/Abstract
The trafficking of leukocytes from the blood stream to the sites of inflammation to find infectious agents
is a hallmark of the innate immune response. Neutrophils, myeloid leukocytes of the innate immune response,
are the so-called “first responders” and will rapidly traffic to the sites of inflammatory insult. Trafficking is
initiated by the leukocyte adhesion cascade, a well-characterized, stepwise sequence of events in which
blood borne immune cells tether, roll, firmly arrest, and migrate on the endothelium and then enter tissues to
perform immune cell functions. These events all occur within blood vessels, normally post-capillary venules,
where cells encounter high shear rates while interacting with and transmigrating through the endothelium.
Recently, an interesting phenomenon wherein certain cells of hematopoietic origin – such as
lymphocytes (T-cells and B-cells) as well as hematopoietic stem and progenitor cells (HSPCs) – will crawl
upstream, against the direction of flow, after arrest on surfaces that present the ligand intercellular adhesion
molecule-1 (ICAM-1). Upstream migration is mediated by the β2 integrin, αLβ2, also known as Lymphocyte
Function-associated Antigen-1 (LFA-1), which binds to ICAM-1. Neutrophils express LFA-1, as well as an
additional receptor for ICAM-1, Macrophage-1 Antigen (Mac-1), which is upregulated when neutrophils are
activated. Our laboratory hypothesized that neutrophils could also be induced to crawl upstream on ICAM-1
if Mac-1 was disabled or blocked, allowing LFA-1/ICAM-1 interactions to dominate. Our preliminary results
show that by either blocking MAC-1 (with an antibody) or by genetically manipulating Mac-1 (using CRIPSR-
Cas9 deletion), neutrophils can migrate upstream on ICAM-1 surfaces, setting the premise for this application.
Here, we propose to determine the critical signals which govern the upstream migration of neutrophils,
how neutrophils generate force when migrating upstream, and identify the physiological implications of
upstream neutrophil migration. In Aim 1 we will determine the key molecular signals involved in upstream
migration in neutrophils, by first analyzing the differential signaling that occurs on ICAM-1 vs. VCAM-1
surfaces and then identify and delete the signals that operate downstream of LFA-1 and Mac-1 using CRISPR
editing. Specifically, we will focus on deleting the signals downstream of Mac-1/ICAM-1 binding to determine
the signals that inhibit neutrophil upstream migration. In Aim 2, we will measure and quantify the forces
generated by neutrophils engineered to migrate upstream using traction force microscopy. Using the
knockouts generated in aim 1, we will measure the differences in the spatial arrangement and magnitude of
force generation between upstream and downstream crawling neutrophils. Finally, in Aim 3 we will determine
the physiological relevance of upstream migration in neutrophils by determining the change in time
needed for altered to transmigrate in vitro on endothelium and the differential trafficking of disabled neutrophils
into the peritoneal cavity in a murine model of acute inflammation.

Public health relevance
Project Narrative Neutrophils are circulating white cells and the recruitment of neutrophils to the sites of inflammation is a hallmark of the innate immune response. We have shown that neutrophils possess the ability to crawl against the direction of shear flow, and our goal is to identify the key receptors and signals that control upstream migration in neutrophils. We hypothesize that upstream migration helps neutrophils to reach the sites of inflammation faster, and manipulating the factors that aid upstream migration may lead to new ways of treating inflammatory disease.